Leveraging Microsurgery and Bioprinting for Rapidly Oriented Vascularized Tissue Engineering

PROJECT SUMMARY/ABSTRACT
Reconstructive surgery is the main treatment strategy to repair craniomaxillofacial (CMF) injuries. However,
surgical options are often antiquated, leading to suboptimal outcomes, both functionally and cosmetically. Tissue
engineered ‘replacement grafts’ represent the next era of reconstructive surgery. However, clinical translation is
still profoundly limited by the lack of prompt vascularization following implantation. This leads to necrosis and
reconstructive failure. Thus, there exists significant clinical need for an effective method that circumvents current
limitations of graft vascularization. Our premise, based upon extensive clinical and tissue engineering expertise
along with rigorous preliminary data is that new surgical and engineering approaches can be used to not only
augment graft vascularization but also purposely orient microvascular ingrowth. We have recently developed a
novel microsurgical tactic termed “vascular micropuncture” (MP) that significantly augments the angiogenic
potential of the surgical site. With MP, we use an ultrafine needle (e.g., 60 µm) to create perforations in the
targeted recipient macrovasculature to enable cell extravasation and angiogenesis, expediting the time to
adjacent scaffold vascularization. With these compelling results, we propose to advance our microsurgical
method using emerging three-dimensional (3D) printing technologies. Based on our unique approach, our
overarching hypothesis is that MP will improve vascularization and survival of 3D printed or bioprinted bone
grafts. To test this hypothesis, we will work on two complementary, but independent, aims. In Aim 1, using a rat
model we will test the effectiveness of MP in vascularizing calvarial defects directly from the sagittal sinus vein.
Following a defined implantation period, vascularization will be quantified via laser doppler, angiography,
immunohistochemistry, and protein analysis. Next, a novel 3D air printing technique will be used to generate
vascularized channels within 3D scaffolds, which will be used to guide the orientation of microvascular ingrowth.
We will also perform a sheep study to demonstrate MP scalability and translatability. In Aim 2, we will assess
the potential of sagittal sinus MP to directly induce the vascularization of bioprinted bone grafts. Sagittal sinus
MP will be coordinated with implantation of an engineered bone graft fabricated via a novel high-throughput
bioprinting method using high-cell density osteogenically committed spheroids. Vascularized bone
volume/density will be evaluated using micro-computed tomography and histology. Accomplishment of these
independent aims together will allow us to establish a groundbreaking surgical approach for tissue engineered
graft vascularization and ultimately improve patient care.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Tissue engineered replacement “grafts” represent the next era of reconstructive surgery, however inadequate vascularization limits success and has precluded clinical translation. We propose to investigate how advances in microsurgery and bioprinting can be used in tandem to circumvent this critical bottleneck. Successful completion of these studies will advance our understanding of microvascular engineering and allow for improvements in patient care.